Regulation, function, and impact of developmental retrotransposon activation

ABSTRACT
Retrotransposons are the most abundant genetic elements in almost all animal cells, making up 38% of the
human genome. Their activation inherently leads to DNA damage and mutations, and this activity is increasingly
appreciated to cause numerous human diseases. Despite their abundance and fundamental impacts on host
physiology and pathology, the study of retrotransposons remains an underexplored area of biomedical research.
Using new tools and technologies developed by my team, in the long-term, we aim to understand how
retrotransposon activity is developmentally regulated, and what are the function and impact of their
developmental activation to the hosts under physiological and pathological conditions.
Our early progress revealed an unexpected convergence among developmental retrotransposon activation, host
immunity, and antiviral response. These results lead to our central hypothesis that developmentally programed
retrotransposon activation primes the immune system to grant the hosts a long-term protection against future
pathogen infections. Toward this hypothesis, we have discovered that Gypsy retrotransposon selectively
becomes active in the newly regenerating tissues during Drosophila metamorphosis. We have also found that
Gypsy activation triggers the production of antimicrobial peptides (AMPs), the effectors of innate immunity.
Excitingly, we further learned that suppressing Gypsy activation during metamorphosis leads flies to succumb
to viral infection at adulthood. Guided by these strong preliminary data, we propose to pursue three Specific
Aims to characterize this Gypsy activation mechanism and to uncover how Gypsy signals AMP production and
ultimately promotes an antiviral response: (1) Characterize how Gypsy activity is regulated during animal
development. (2) Elucidate the molecular mechanisms by which Gypsy activation primes host innate immunity.
(3) Define the long-term impact of Gypsy activation on combating pathogens.
Collectively, our proposed research will broadly impact the field by identifying new mechanisms that control
retrotransposons and characterizing the influence of retrotransposon on host immunity. Given that the activation
of retrotransposon likely contributes to inflammation in neurodegenerative disease and increases
immunogenicity of cancer cells, our findings will potentially provide new perspectives to harness them for treating
related diseases.

Public health relevance
PROJECT NARRATIVE Programmed retrotransposon activation likely promotes animal development. Our proposed studies aim to understand during development how retrotransposon activity is regulated and what is the molecular function and long-term impact of their activity to the hosts. This research will have the potential to provide new insights on controlling retrotransposons and on harnessing their developmental roles to improve human health.